NSF: 2018 General Social Survey

The General Social Survey (GSS) is a nationally representative personal interview survey of the United States adult population that collects data on a wide range of topics: behavioral items such as group membership and participation; personal psychological evaluations including measures of well-being, misanthropy, and life satisfaction; attitudinal questions on such public issues as crime and punishment, race relations, gender roles, and spending priorities; and demographic characteristics of respondents and their parents. NCI added 10 PROMIS global health items to the GSS.